Shared Resources Core 2: Quantitative Proteomics Core

Project Summary
The Quantitative Proteomics core led by Dr. Benjamin Garcia will provide cutting-edge mass spectrometry
(MS) based proteomics technologies to the P01 Project team members to help elucidate biochemical
mechanisms involved in histone and histone-like mutations in human cancers. These MS approaches will
include quantitative experiments to understand protein expression and post-translational modifications (PTMs)
on histone and non-histone proteins from both cultured and primary cell lines, tissue/tumors and formalin fixed
paraffin embedded (FFPE) archived samples. Although most researchers in the epigenetics and chromatin
biology fields utilize antibody based methods for histone modification characterization, antibodies have many
technical issues (such as epitope occlusion), which confound the analyses. Mass spectrometry therefore
provides a more unbiased and complementary approach, that is also more sensitive and accurate for protein
PTM analysis. The Garcia Lab has for over a decade now developed methods for histone PTM analyses. Here
in this propose we plan to continue to expand our proteomics toolbox to allow P01 team members to be able to
characterize 500 histone PTM sites in rapid fashion, perform quantitative analyses of histone combinatorial
modifications, and determine which oncogenic histone mutations affect chromatin structure. Additionally, we
will explore the downstream protein signaling pathways that are altered in epigenetically driven human
cancers, as transcriptional profiles do not always provide the most accurate pictures of protein expression.
!

Public health relevance
Project Narrative Mutations to several epigenetic related genes have been discovered across several classes of human cancers. This research will help define altered chromatin and signaling pathways due to these gene mutations, which will inform mechanisms and potential design of therapeutics for treatment of human cancers.